Medicaid Expansion and Quality, Utilization and Coordination of Health Care for Veterans with Chronic Kidney Disease

Background: [The 2019 US Department of Health and Human Services Advancing American Kidney Health
Initiative aims to “improve care coordination…for people living with kidney disease.” Accessing care from
multiple systems and insurers can result in lapses in care coordination, and] patients with serious conditions,
such as chronic kidney disease (CKD), are especially vulnerable to poorer outcomes from fragmented care.
[While Medicaid expansion, as occurred with the Affordable Care Act (ACA),] is effective in improving access
to health care and health outcomes for the uninsured, the significant number of Veterans enrolled in VA (who
already have access to comprehensive care) who gained access to Medicaid with expansion face increased
risk of care fragmentation. Increased use of non-VA care as a result of the MISSION Act poses similar risks.]
Significance/Impact: As more Veterans access care from a mixture of VA and non-VA sources, VA needs to
adopt strategies for cross-system care coordination to ensure effective and efficient care for Veterans. This
requires understanding how Veterans utilize care when multiple options are available. Patients with advanced
CKD have highly complex care needs. Lack of well-coordinated care may increase unnecessary care and
worsen outcomes for such patients. Examining use and outcomes data will illustrate multiple aspects of access
and care coordination for Veterans with chronic conditions and anticipates implementation of the MISSION Act.
Innovation: [That some states opted out of ACA Medicaid expansion allows for a natural experiment where
changes in quality of care and utilization over time can be compared between states that did and did not
expand Medicaid. The team will use VA, Medicare, and recently-released post-expansion Medicaid claims data
to evaluate how Medicaid expansion influences Veteran choices of health system use and CKD treatment.]
Specific Aims: Aim 1: To determine the characteristics of Veterans and Veterans with CKD who are most
likely to enroll in both Medicaid and VA. Aim 2: To determine the impact of dual enrollment on the utilization of
health care services for Veterans with advanced CKD and to create a reference tool to enhance coordination
for these patients. Aim 3: To evaluate differences in quality of health care and costs among Veterans with
advanced CKD in states that have expanded Medicaid and those that have not.
Methodology: Claims data [from 17 states (7 that expanded Medicaid in 2014 and 10 that did not) in the
Medicaid Analytic eXtract (MAX) file for 2011-2014] are included. A difference-in-difference model will estimate
the association of state Medicaid expansion with [changes in Veterans’ dual-enrollment status (VA and
Medicaid) and in utilization and outcomes for Veterans with CKD. Utilization analyses will consider outpatient
visits, emergency department visits and hospital admissions recorded in VA and Medicaid data. Outcomes to
be considered are time-to-mortality, emergent vs. elective initiation of dialysis, and costs to the health care
system.] Each analysis contains demographics, comorbidity and illness severity. For all aims, separate models
for low-income (Priority 5) Veterans are estimated as a sensitivity check. [In addition, strategies to support
enhanced care coordination will be gathered from interviews with renal care teams and organizational leaders
then developed into a care coordination reference tool for those who provide care for patients with kidney
disease. Input from Veterans and patients will be incorporated at each stage of the interview and reference tool
development process.
Next Steps/Implementation: Veteran/patient and VA operational (National Kidney Program; Office of
Veterans Access to Care) partners will be provided with interim and final findings to guide strategic planning
and to inform programs that support optimal care for Veterans with access to multiple sources of care. Results
from this project will be of great importance as stakeholders plan for Veteran needs in the form of direct health
care services and effective care coordination, and as they make state and national policy recommendations.]

Public health relevance
Veterans who access health care from multiple systems are at risk of experiencing fragmented care. Fragmented care can lead to feelings of mistrust, abandonment, and isolation. Fragmentation created by dual use of VA and non-VA services creates inefficiency, unnecessary care, and worse outcomes. The 2018 MISSION Act and Medicaid expansion under the ACA result in more health care options for Veterans, but also increased risk of fragmented care. We will assess choices Veterans made about their care after Medicaid expansion. We will focus on a group particularly vulnerable to fragmented care–patients with complex health care needs from advanced chronic kidney disease. As VA incorporates more non-VA sources of care under the MISSION Act, understanding trade-offs between increasing access and ensuring high quality, coordinated care will become a central question for VA. Understanding how Veterans choose to access care when given multiple options is key to making health system improvements in resource deployment and care coordination.